Intestinal Homeostasis Induced by Commensals

ABSTRACT
While multidrug-resistance transporters including P-gp and MRP2 are generally studied for their
role in exporting drugs and foreign compounds from the cell, our studies indicate that these efflux
pumps expressed at the apical surface of intestinal epithelial cells provide a critical link in
communication between sentinel functions of mucosal barriers and the immune system.
Understanding how this P-gp/eCB anti-inflammatory arm is regulated will provide crucial insight
into how dysfunction may promote intestinal inflammation and help identify potential new
therapeutic targets. Because the resident microbiota is known to contribute to tolerance and
homeostasis in the healthy intestine, the central hypothesis we aim to test is whether the normal
microbiota actively drives the P-gp/eCB axis to prevent unnecessary inflammation. Our pilot
studies indicate that the microbiota does influence P-gp expression and function, providing a
unique foundation for further cause-effect studies. No data have previously demonstrated a link
between the microbiota and eCBs or any other epithelial lipid signals, and may well provide great
insight into a novel system. Bridging this gap could help explain how commensal bacteria can
stabilize a state of tolerance and how genetic modification of specific pathway elements might
predispose individuals to conditions of inflammatory bowel disease (IBD). To begin addressing
these questions, in Aim 1 of this application will combine in vitro (including human colonoids) and
in vivo murine model systems, as well as use healthy and UC patient stool, to more deeply
understand the microbial consortia that collectively maximize P-gp expression and function. Aim
2 is designed to identify the microbial metabolites that drive activation of P-gp expression and
eCB secretion to maintain an anti-inflammatory tone in the intestinal epithelium. Thus,
transcriptomics and metabolite analyses will be performed to provide new information regarding
microbial genes, gene clusters, and their metabolic products implicated in maintaining an anti-
inflammatory tone in the intestinal epithelium through regulation of the P-gp/eCB axis. In Aim 3
we will employ novel computational methods will to uncover the inter-microbial network responses
and the ecological structure of a stable community that is able to induce P-gp expression.
Collectively, knowledge of the pathways that coordinate the maintenance of the P-gp/eCB axis
will require a comprehensive understanding of distinct signals regulating intestinal homeostasis,
how multiple signals are integrated in the complex intestinal environment, and pathways that
modulate host-microbe interactions. Consequently, this proposal will directly advance novel
biological principles with guidance of new therapeutic intervention strategies.

Public health relevance
Public Health Narrative Regulated recruitment and migration of acute inflammatory cells termed neutrophils (PMN) into the intestine and across the specialized epithelium that lines it is critical for host defense, yet dysregulation of this process is associated with disease. Because the resident microbiota is known to contribute to tolerance and homeostasis in the healthy intestine, the goal of this proposal will examine whether the normal microbiota actively drives the P-gp/eCB axis to maintain a homeostatic anti-inflammatory tone in the intestinal epithelium. Understanding this process could help explain how commensal bacteria can stabilize a state of tolerance and how genetic modification of specific pathway elements might predispose individuals to conditions of inflammatory bowel disease (IBD).